Establishment of Specific Free Rhesus and Pigtail Macques Colonies

DESCRIPTION (provided by applicant): The Indian rhesus macaque develops a disease that closely mimics human acquired immunodeficiency syndrome (AIDS) when infected by simian Immunodeficiency virus (SIV) or chimeric simian-human immunodeficiency viruses (SHIV), and represents the best animal model for HIV Infection. Preclinical vaccine development is heavily dependent on the SIV and SHIV rhesus macaque models. The value and utility of the model are markedly enhanced by improving the level of microbial and genetic characterization. Macaques free of ubiquitous viruses that are homologues of human viruses responsible for opportunistic infections are essential for a growing number of AIDS-related opportunistic infection models and for viral vaccine vector development based on these agents. The utility of macaque models for immunological research has been hindered by the unprecedented complexity of their major histocompatibility complexes. Comprehensive MHC genotyping has the potential to revolutionize the use of macaques in infectious disease research and to guide functional immunology studies. MHC-restricted cellular immune responses are key in protective immunity and resistance to infectious diseases. The comprehensive objective of this application is to increase the capacity of the ONPRC AIDS Research Expanded SPF Breeding Colony to provide genetically characterized lndian-origln rhesus macaques free of a broad number of enzootic and zoonotic agents to enhance the usefulness of the resource for cutting edge opportunistic agent and vaccine research. PUBLIC HEALTH RELEVANCE (provided by applicant): Expanded breeding of specific pathogen free Indian-origin rhesus macaques and extended MHC genotyping have repeatedly been identified as priorities for mitigating chronic shortages of animals for research and to improve their usefulness to better understand MHC-restricted cellular immunity. The ONPRC Expanded SPF rhesus macaque breeding colony is directly responsive to these national priorities.

Public health relevance
(provided by applicant): Expanded breeding of specific pathogen free Indian-origin rhesus macaques and extended MHC genotyping have repeatedly been identified as priorities for mitigating chronic shortages of animals for research and to improve their usefulness to better understand MHC-restricted cellular immunity. The ONPRC Expanded SPF rhesus macaque breeding colony is directly responsive to these national priorities.